Assessing Access to Language in the Real-World and Neural Language Processing in Preschoolers who are Deaf or Hard of Hearing

Abstract
Children who are Deaf or Hard of Hearing (CDHH) developing spoken language are at risk of language delays.
Language difficulties in CDHH are partially explained by hearing status factors (i.e., age of amplification) as well
as reduced exposure to caregiver language input. Recent models of language acquisition emphasize that noise
in the environment can further limit access to caregiver input. Thus, the premise of this work is that CDHH
exposed to both limited caregiver input and reduced access to language, face the highest risk of language delays.
Our long-term goal is to study longitudinally effects of overall language experiences on CDHH's behavioral and
neural language development. In this proposal, we recruit a heterogenous group of 40 preschool CDHH and
an age-matched control group of children with typical hearing (CTH). We aim to develop and assess the
effectiveness of a novel Speech Accessibility Index (SAI). The SAI is designed to quantitatively evaluate
children's access to language in real-world environments (Aim 1). In addition, we aim to assess the feasibility of
evaluating preschooler's neurophysiological correlates of language processing in noise using alpha power (Aim
2). We hypothesize that the SAI will be effective explaining variability in language skills in both groups, and that
children will engage cognitive and language areas of the brain (reflected in alpha power modulations) to
effectively listen to sentences in noise. This research uses novel ecologically valid measures of children's
auditory environments as well as cutting-edge electroencephalography analyses. Thus, we provide an innovative
methodology that holistically examines early language experiences, neural mechanisms involved in language
processing in real-world environments, and associations of these factors with preschooler's behavioral
outcomes. Thus, we will enhance our comprehension of factors affecting language acquisition in CDHH and
CTH. Moreover, the study will trigger the development of auditory-based intervention strategies aiming to
facilitate access to language in the real-world for CDHH. Therefore, this research has the potential to improve
long-term lifelong outcomes of CDHH.

Public health relevance
Project Narrative This project aims to investigate how access to language in the real-world affects the development of language skills of children who are Deaf or Hard of Hearing. It also utilizes EEG to study neural language processing in noisy environments in this population. The study will enhance our understanding of behavioral and neural language development and will inform future interventions for children who are Deaf or Hard of Hearing.